Summer Substance Abuse Research Training (SummerSART)

Abstract
Underrepresented minority researchers and researchers from disadvantaged backgrounds are
underrepresented in both research in general and in funding from NIDA. The Summer
Substance Abuse Disorders Research Training (SummerSART) at Charles R. Drew University
(CDU) and UCLA builds on the highly successful SART grant (R25DA050723, funded in April
2020) that, in turn, built on 15 years of DIDARP/MIDARP program (PI: Friedman) in which 159
mostly minority students received a meaningful research experience in substance use disorder
fields along with training and mentorship. This summer grant proposes to provide hypothesis-
driven research, courses for skill development and mentorship to eight undergraduates in
established training programs at CDU that require a research project/thesis as well as other
undergraduate students throughout the country with the goal of training the next generation of
substance use disorder researchers. Trainees will be allowed to choose a mentor from one of
21 senior substance use disorder researchers at CDU and UCLA and will also have the option
of one community faculty mentor that will help the trainee with dissemination and community
engagement, one of the specialties of CDU.
Training will include four 2-hour long research institutes, five 90-minute webinars in hot topics in
substance use research, a four-part UHI research training course, special seminars, a weekly
journal club in substance use research and a four-part responsible conduct of research series.
All programs are designed to inspire and provide the trainee skills so that they are more
competitive in their future careers in substance use disorder research.
We expect this summer R25 grant will train the next generation of substance use disorder
researchers and provide them with skills that will allow them to succeed at their next research
level.

Public health relevance
Narrative Although substance use disorders are a health disparity that occurs more commonly in minority and low-income populations, underrepresented minority researchers and researchers from disadvantaged backgrounds are less like to go into research in this field and less likely to receive funding from NIDA. The Summer Substance Abuse Disorders Research Training (SummerSART) at Charles R. Drew University (CDU) and UCLA builds on the highly successful SART grant that, in turn, built on 15 years of DIDARP/MIDARP program (PI: Friedman) in which 159 mostly minority students received a meaningful research experience in substance use disorder fields along with training and mentorship. This grant proposes to provide research opportunities and courses for skill development and mentorship to undergraduates over the summer with the goal of training the next generation of substance use disorder researchers.